Cocaine Abuse and HIV Comorbidity: Relapse-Related Brain Pathology.

SUMMARY Cocaine abuse is prevalent in HIV-infected individuals. Drug abstinence greatly improves the health and well-being of the comorbid individual, but relapse to drug-taking remains exceptionally high in this vulnerable population. In the brain, the actions of HIV-associated proteins and cocaine may overlap on glutamatergic pathways and the innate immune system. Glutamate transmission clearly regulates relapse and a role for inflammation in addiction is becoming appreciated. Thus, relapse-related neuropathology in the comorbid condition is likely to be vastly different from that described for cocaine abuse alone. The overarching objective of this research program is to decipher neurobiological mechanisms that underpin abstinence and relapse to cocaine-taking during HIV-infection. This objective requires valid animal models of the human comorbid condition. Intravenous (i.v.) self-administration protocols are the “gold standard” facsimile of human drug- taking. To our knowledge, we are one of only two laboratories world-wide that have implemented these protocols for cocaine in a rodent model of human HIV/AIDS, and there are no studies using a comorbid model to study relapse to cocaine-taking. Thus, the interactions between HIV infection and cocaine use on the neurobiological underpinnings of relapse are completely unexplored. Moreover, i.v. does not emulate the routes of cocaine administration used by humans. To fill these gaps, the objectives of this R21 project are to implement a new, clinically relevant model of the human comorbidity, and to use this model to explore immunological and glutamatergic mechanisms that underlie relapse to cocaine-taking in the context of HIV. The model will be Fischer 344 HIV-1 transgenic (Tg) rats that self-administer vaporized cocaine via inhalation. Our overarching hypothesis is that behavioral and brain indices of relapse, i.e., cocaine- seeking and increased glutamatergic synaptic strength, respectively, will be enhanced in Tg rats with a history of inhaled cocaine. We will test this hypothesis and meet our project objectives by experiments grouped into two Specific Aims. Aim 1 will establish relapse-testing in HIV-1 Tg rats. To optimize contingent cocaine-taking, we will implement inhalation delivery of vaporized cocaine. This method emulates a delivery route and rapid brain entry of cocaine, used by human cocaine addicts, and avoids potential immunological complications imposed by surgery and chronic indwelling catheters needed for i.v. delivery. A cue-reactivity protocol will be used to indicate vulnerability to relapse. We hypothesize that cue-reactivity will be greater in cocaine self-administering Tg rats than either condition alone. Aim 2 will determine the contribution of HIV-1 proteins to neuropathology associated with cocaine-seeking. Over activity of glutamatergic AMPA receptor (AMPAR)-mediated transmission within the nucleus accumbens core (NAc) is linked to cocaine-seeking. We reveal here that abstinence from i.v. cocaine self-administration by male Tg rats greatly exaggerated excitability of NAc neurons. HIV-1 toxic proteins promote glutamatergic excitotoxicity and TNFα regulates AMPAR. These outcomes help guide the working hypotheses that inflammation-promoted, AMPAR-mediated increase in NAc synaptic strength are exaggerated in drug-seeking cocaine self-administering Tg rats. These strategies will provide the first behavioral and neurobiological characterization of relapse to cocaine in the context of chronic HIV-1 proteins, and outcomes will form the platform for identifying relapse reduction targets to be explored in a future R01 application.

Public health relevance
NARRATIVE The combination of cocaine abuse and HIV-infection accelerates brain damage that can accompany either condition alone. Even when the cocaine abusing individual is motivated to stop taking the drug, relapse to drug-taking is exceptionally high. To understand this neurobiology of this comorbidity requires valid small animals that exhibit key elements of the brain disease. This project is designed to develop a completely new laboratory rat model of relapse in cocaine-abusing HIV-infected humans. We then will use this model to examine brain pathology. These studies will help identify brain targets for new relapse-reduction therapies to provide relief for those who suffer from cocaine addiction and HIV/AIDS.